Elevating Mentoring Possibilities for Overcoming Withstanding Educational Roadblocks in Sickle Cell Disease (EMPOWER SCD): STEMM mentoring for youth with sickle cell disease

Project Summary/Abstract
One fifth of the school-age population in the US have a chronic medical illness or disabling condition that
puts them as an educational disadvantage.1 This includes children with sickle cell disease (SCD), a chronic,
periodically disabling medical condition that principally affects people of sub-Saharan Africa and South Asia
(India) descent. For combination of medical, physical, and social reasons, adolescents, and teens with SCD are
at particular risk for missing school, falling behind in their education, and failing to enjoy opportunities to develop
an interest in STEMM (Science, Technology, Engineering, Mathematics, and Medicine) subjects. Elevating
Mentoring Possibilities for Overcoming and Withstanding Educational Roadblocks in Sickle Cell Disease
(EMPOWER SCD) proposes to use children’s hospitals and their affiliated clinics as informal science education
centers wherein near-peer mentors (undergraduate engineering and health professional students from local
universities) will help middle and high school students with SCD foster an interest in STEMM.
(Aim 1) EMPOWER SCD near-peers will facilitate biomedical engineering demonstrations, innovative hands-
on activities, presentations by senior role models who are STEMM professionals, and other activities to promote
STEMM-identity formation. Target project outcomes for EMPOWER SCD participants include improved
academic performance, the formation of a STEMM identity, and the development of aspirations for pursuing
post-secondary education in STEMM fields.
The benefits of near-peer mentorship have been well established in other educational settings. For example,
medical schools have found that near-peer teaching/mentoring among medical students2,3 can result in positive
social, cognitive congruence, and academic outcomes4 and that college students who have been paired middle
school (11 to 14-year-olds) and high school students (14 to 18-year-olds) leads to personal and professional
growth among mentors and increased interest and engagement in STEM among mentees5.
(Aim 2) We will create a train-the-trainer program designed to enhance the skills of EMPOWER SCD near
peers in addressing the unique challenges faced by adolescent and teenage students with sickle cell disease,
in facilitating the development of STEMM identity among mentees, and in providing academic and personal
guidance. We will also seek to match demographic characteristics such as race and gender among mentors and
mentees in order to promote bonds of trust that can lead to deeper and earlier connections6. In sum, EMPOWER
SCD will seek to improve STEMM opportunities for children with sickle cell disease by placing them in
partnerships with near-peer mentors. The overall goal of EMPOWER SCD is to inspire and help enable
people with sickle cell disease in advancing academically toward becoming researchers, physicians,
and engineers capable of diversifying the workforce and making a positive impact on society.
1

Public health relevance
Project Narrative Elevating Mentoring Possibilities for Overcoming Withstanding Educational Roadblocks in Sickle Cell Disease (EMPOWER SCD): STEMM mentoring for youth with sickle cell disease The goal of this work is to create a near-peer mentorship program for youth with sickle cell disease to increase the likelihood of pursuing post-secondary education and careers in STEMM (medicine) fields. EMPOWER SCD will connect youth with biomedical engineering educational experiences, teaching and learning opportunities, and STEMM identity formation activities. This work will positively impact the student’s educational aspiration, interest in STEMM subjects, STEMM identity, and drive them to become future researchers, physicians, and engineers. 1